Interleukin-31 at the neuroimmune interface of pruritus and dermatitis

PROJECT SUMMARY/ABSTRACT

Despite the clinical and psychosocial burden of itch in atopic dermatitis (AD), effective treatment options
are limited. Interleukin-­31 (IL-­31), an inflammatory factor produced by skin T cells, has emerged as a powerful
mediator of both itch and rash. When administered to skin, IL-­31 can trigger dermatitis and activate cutaneous
afferent sensory nerves to drive scratching behavior. Therapeutic antibodies directed against IL-­31 and its
receptor, IL31RA, have shown promise in clinical trials for AD and chronic pruritus. Yet fundamental questions
about IL-­31 biology remain. Which cells make IL-­31? What pathways does IL-­31 actuate in sensory afferent
neurons? How do IL-­31 signals integrate with other pruritogenic pathways in the context of inflammation?
Improved definitions of the sources, pathways, and effector functions of IL-­31 will substantially advance
mechanistic understanding of the links between inflammation and itch.
Dr. Fassett’s long-­term research goal is to elucidate cellular and molecular mechanisms responsible for
atopy-­associated pruritus. The objective of this proposal is to use genetic mouse models to address the in vivo
biology of IL-­31 by examining the effects of endogenous IL-­31 on cutaneous inflammation and pruritus sensory
pathways. Dr. Fassett’s central hypothesis is that IL-­31 couples itch and rash via its combined effects on
pruritoceptive afferent pathways and cutaneous Th2 cytokine-­mediated inflammation. Dr. Fassett will test this
hypothesis using three specific aims. In Aim 1, Dr. Fassett will use novel IL31-­deficient animals and IL31-­
tdTomato reporter animals to determine how multiple IL-­31 source cell types functionally impact cutaneous Th2
inflammation in vivo. In Aim 2, she will elucidate the contribution of IL-­31:IL31RA to atopy-­associated
pruritoceptive pathways including itch sensation and neurogenic inflammation. In Aim 3, she will determine how
IL-­31 alters afferent responses to other pruritogens, including Th2 cytokines. This project is relevant to the
mission of NIAMS because it explores the mechanism of action of IL-­31, a biologic target of potentially great
therapeutic value for atopic dermatitis and for pruritus associated with other inflammatory skin diseases.
Dr. Fassett is an MD PhD-­trained Dermatologist working as a post-­doctoral research fellow at the University
of California, San Francisco. She is applying for a K08 Award to support her goal of becoming an independent
physician scientist. UCSF’s exceptional training environment will support her efforts. Critical elements of her
career development plan include mentorship by Dr. Mark Ansel, expert in cytokine biology and Th2 inflammation;;
co-­mentorship by Dr. Allan Basbaum, expert in pain and itch;; guidance by a multidisciplinary advisory committee
including senior physician-­scientists;; coursework in advanced experimental neuroscience;; and professional
development activities. Taken together, this career development plan will provide Dr. Fassett with a strong
foundation on which to build her growing expertise in the neuroimmune pathways that couple itch and rash.

Public health relevance
NARRATIVE Atopic dermatitis is an itchy chronic inflammatory skin disease prevalent among children and adults. The atopic dermatitis- associated cytokine IL- 31 contributes to both skin inflammation and itch sensation, but its cellular sources and mechanisms of action are not well characterized. We propose to use novel mouse genetic tools to map IL- 31 expression patterns and functionally define specific molecular pathways that link inflammatory cells to IL- 31- responsive itch pathways in skin.